Merkel cell polyomavirus T-Antigen mediated reprogramming in adult epidermis

ABSTRACT
Merkel cell carcinoma (MCC) is a poorly understood cutaneous malignancy with viral etiology. Most MCC tumors
feature monoclonal integration of Merkel cell polyomavirus (MCV), which expresses viral T-Antigens (T-Ags).
Small T-antigen (sT-Ag) acts as a transcriptional co-regulator, while Large T (LT-Ag) principally functions to
sequester retinoblastoma protein (RB1) to de-regulate the cell cycle. The T-Ags are responsible for driving
tumorigenesis in T-Ag expressing (T-Ag+) MCC tumors: few mutations are present in T-Ag+ MCC tumors,
including in tumor suppressors RB1 and TP53, whose activities are instead repressed by the functions of the T-
Ags. Latent MCV infection that doesn’t result in T-Ag production is found in a substantial portion of the human
population, however MCC occurs only rarely. Much of what occurs between latent infection and the appearance
of a full-blown T-Ag+ MCC tumor has not been explored due to the lack of in vivo MCC tumorigenesis models.
Among the unanswered questions is how the MCV T-Ags induce a tumor transcriptional program that features
markers of multiple cell lineages, including both epidermal stem cell and neuroendocrine fates.
Previous research in our laboratory determined that SOX9-expressing (SOX9+) hair follicle cells, which give rise
to mechanosensory Merkel cells during fetal development, are also Merkel cell progenitors in adult skin.
Hypothesizing that T-Ags reprogram cells in the Merkel cell lineage to cause MCC, I generated transgenic mice
that express sT-Ag and ablate RB1 to mimic LT-Ag in SOX9+ cells. These mice developed tumors that were not
bona-fide MCC but expressed neuroendocrine markers, making these mice a valuable model in which to study
mechanisms of T-Ag mediated reprogramming. Analysis of tumors at early time points revealed that re-
programming occurred only in specific sub-populations of SOX9+ cells and that reprogrammed cells were highly
apoptotic. Therefore, I hypothesized that specific landscapes of gene accessibility are required for T-Ags to
induce reprogramming from an origin cell and that suppressing p53 mediated apoptosis is required for MCC.
I propose to leverage the model of SOX9-derived, T-Ag driven neuroendocrine tumors to generate novel insights
into the mechanisms of T-Ag mediated reprogramming. I will use integrated epigenetic and transcriptomic
sequencing analyses to characterize the gene accessibility and transcriptional landscape required for T-Ag
mediated reprogramming to occur and identify a native cell type that is competent to undergo reprogramming.
Furthermore, I will study how p53 suppression, which is commonly observed in MCC tumors, contributes to
advancing reprogramming. Altogether, the proposed studies will establish a model of T-Ag mediated
reprogramming in vivo and discover factors that enable T-Ags to reprogram cells. This research will not only
make valuable contributions to the field of MCC research but also to my training by exposing me to molecular
techniques and genomic and epigenomic analyses that are foundational to an independent research career.

Public health relevance
PROJECT NARRATIVE The transcriptional changes through which Merkel cell polyomavirus T-antigens (T-Ags) incite tumorigenesis and neuroendocrine reprogramming in Merkel cell carcinoma (MCC) are poorly elucidated but critical to understanding the biology, origin, and vulnerabilities of these tumors. I propose to leverage in vivo murine models of T-Ag mediated reprogramming to elucidate the mechanisms of how T-Ags drive reprogramming to the neuroendocrine lineage and interrogate the requirement for tumor suppressor dysfunction to promote the acquisition of neuroendocrine phenotypes associated with MCC. These studies will elucidate a currently obscure area of T-Ag and MCC biology and establish a foundation for further exploration of T-Ag mediated reprogramming mechanisms and therapeutic targets.